Constructing a growth-promoting pathway for functional regeneration after SCI

Project Summary
Spinal cord injury (SCI) is among the most disabling conditions affecting wounded members of the U.S. military.
Unfortunately, no effective treatment has been available for patients with SCI. Developing novel repair
strategies to mitigate the devastating nature of SCI and translating them to the clinic are urgent medical needs
for our veterans with SCI. For functional recovery to occur after a SCI, regenerated axons need to follow the
topography of grafted cells/growth factors and make accurate connections with specific subsets of neurons or
subregions of dendritic architecture. The lumbar motoneurons (MNs) are the final common pathways for motor
output to the hindlimbs and they undergo dendritic atrophy and synaptic stripping after an above-level SCI. The
goal of our research is to reestablish neural circuitry across the lesion gap and to promote functional recovery
after SCI. We hypothesize that a growth promoting pathway composed of grafted Schwann cells (SCs)
overexpressing a growth factor called glial cell line-derived neurotrophic factor (GDNF) will promote the growth
of descending propriospinal tract (dPST) axons across the lesion gap with extension caudally to the lumbar
MNs in the host spinal cord, and that these axons will form target-specific synaptic contacts with lumbar MNs
overexpressing a neurotrophin called neurotrophin-3 (NT-3). We also hypothesize that such a combinatorial
approach will lead to greater recovery of function than either single treatment. Using a clinically-relevant
contusive SCI model at the 9th thoracic (T9) level, transplantation of SCs-GDNF to form a continuous axonal
growth-promoting pathway across and beyond a SCI, and adeno-associated virus serotype 2 expressing NT-3
(AAV2-NT-3) gene transfer approach to enhance NT-3 expression in lumbar MNs, we will determine (1)
whether a continuous axonal growth-promoting pathway formed by grafted SCs-GDNF will promote dPST
axonal growth through and beyond a contusive SCI, innervate the lumbar MNs pools, and enhance
electrophysiological and locomotor recoveries; (2) whether combining the axonal growth-promoting pathway
formed by SCs-GDNF with expression of NT-3 in lumbar MNs will synergistically enhance the innervation of
dPST axons on lumbar MNs and, therefore, promote better recovery of function as compared to either
treatment alone; (3) whether dPST-MN neurotransmission is necessary for hindlimb locomotor recovery in the
combinatorial treatment; and (4) the molecular signature of lumbar MNs after the reestablishment of dPST-MN
circuitry and synaptogenesis. Completion of this proposal will allow us to reveal mechanisms fundamental to
rebuilding neural circuitry of the dPST-MN pathway and to identify new therapeutic strategies for locomotor
recovery after clinically-relevant contusive SCIs.

Public health relevance
The goal of our research is to reestablish neural circuitry across the lesion gap and to promote functional recovery in a rat model of spinal cord injury (SCI). We hypothesize that a growth-promoting pathway composed of grafted Schwann cells (SCs) overexpressing a trophic factor called glial cell line-derived neurotrophic factor (GDNF) will promote the growth of descending propriospinal tract (dPST) nerve fibers across the lesion gap with extension caudally to the lumbar motoneurons (MNs) in the host spinal cord, and that these nerve fibers will form target-specific connections with lumbar MNs overexpressing a neurotrophic factor called neurotrophin-3 (NT-3). We also hypothesize that such a combinatorial approach will lead to greater recovery of function than either single treatment. Completion of this proposal will allow us to reveal mechanisms fundamental to rebuilding neural circuitry of the dPST-MN pathway and to identify new therapeutic strategies for locomotor recovery after clinically relevant SCIs.